New Tools to Image Tau Protein Form and Function

Project Summary
The process by which tau moves from its soluble form to neurofibrillary tangles has been studied for many
years, but only recently has the importance of an intermediate liquid-liquid phase separation step been
shown. Indeed, the assortment of tau into these biomolecular condensates is increasingly seen as a key
feature underlying both normal cell function and disease. These liquid-liquid phase separations often
proceed liquid-to-solid phase transitions that in turn lead to the protein aggregates underlying tau protein
misfolding diseases including Alzheimer’s disease. While the community can observe neurofibrillary
tangles using thioflavin T and early-stage biomolecular condensates with FRET, there is no single imaging
approach that can map and measure tau in its all three forms in living cells: soluble, liquid-liquid phase
separation, and liquid-solid phase separation forms. This work will solve this major limitation with a peptide-
based probe specific to tau and aggregation-induced emission (AIE). In AIE, a molecule analogous to a
fluorophore produces light proportional to the degree of molecular sequestration and restricted movement.
Signal is “off” when the molecule is “floppy” and “on” when locked in place. The use of AIE is significant,
innovative, and critical here because the AIE signal will directly measure tau as it becomes compressed
into increasingly confined environments (monomers to liquid condensates to fibrillary aggregates). Thus,
our testable hypothesis is that fluorescence will increase with the type of condensate: soluble<liquid-
liquid<liquid-solid. Aim 1 of the work will build and characterize the probe. We will test the probe with
different concentrations of recombinant tau including different tau isoforms, different degrees of tau
phosphorylation, and tau from different species. Aim 2 will use the probe in cultured cells (Aim 2A) and
histology sections of rodent brains (Aim 2B). We will transfect cells to overexpress tau, induce tau
biomolecular condensate and fibril formation, and then map and measure the location of tau forms in these
cells using confocal microscopy. The PS19 animal model is available “off the shelf” and will used with
histology to understand the distribution of tau BMCs in different brain regions; we will also stain the nuclear
pore complex to understand the interactions of these different tau condensates with the nucleus. The
significance of the work is apparent by the grave impact Alzheimer’s disease has on society. Innovation is
underscored by the ability to image tau across multiple domains of condensation, the ability to map tau
condensate interactions with other organelles, and the use of AIE to monitor tau molecular movement.
Finally, the probe uses a peptide with known specificity to tau in contract to gold standard probes like
thioflavin T. This work is feasible because of the PI’s expertise in imaging agents, peptide probes, and cell
and animal models; the Co-I’s expertise in tau pathologies; and our peer-reviewed preliminary data.

Public health relevance
Project Narrative Patients with Alzheimer’s disease have long been known to have tangles or plagues of proteins in their brain, and these protein aggregates strongly correlate to the extent of disease. People have recently shown an intermediate stage of protein between the aggregated form and the soluble form, but this intermediate stage is difficult to study. This work will prepare a contrast agent that specifically images these liquid-phase protein condensates to help map and measure their quantity in cells and the brains of mouse models of Alzheimer’s disease and ultimately improve treatments for patients.